Addressing HPV vaccination disparities through tailored messaging for hesitant families

PROJECT SUMMARY
Human papillomavirus (HPV) causes over 34,800 cancers in the United States each year that disproportionately
affect Black women. The HPV vaccine is highly effective, but less than half of adolescents aged 13-15 years
have received recommended doses, with Blacks having the greatest disparity in completion. HPV vaccine
hesitancy is associated with under-vaccination and refusal. An estimated 23% of parents with adolescents are
hesitant about the HPV vaccine, but parents’ concerns vary due to a myriad of individual, interpersonal, and
sociocultural factors. Effective strategies to overcome parents’ concerns are needed, especially among Black
families, who have higher prevalence of general vaccine hesitancy and medical mistrust due to racial inequities.
The purpose of this NCI Transition Career Development Award (K22) is to support me through specific training
and research experiences as I become an independent investigator specializing in multilevel cancer prevention
interventions to reduce cervical cancer disparities. Building on my strong health services research and behavioral
science background in HPV screening, I will develop expertise in HPV vaccination communication, community-
engaged intervention planning, and intervention trials. The objectives of this rigorous mixed methods proposal
are to: (1) use a stakeholder-engaged approach to develop and refine an interactive, tailored text messaging
intervention to address Black parents’ HPV vaccine hesitancy determinants and vaccination barriers; and (2)
conduct a two-arm pilot RCT to determine feasibility, acceptability, appropriateness, and preliminary efficacy of
the tailored messages compared to untailored messages. Following a provider’s initial recommendation, the
intervention will allow parents of young adolescents to process HPV vaccination information on their preferred
timeline, answer lingering questions and concerns, provide links to additional information from trusted sources,
and support connections to local resources to help overcome barriers. By accomplishing these aims, I will
address current gaps in strategies to increase vaccine confidence and motivation among high-risk Black families.
Rutgers Cancer Institute with its well-funded behavioral research program, robust research infrastructure, and
deep community connections is an exceptional environment to conduct high-impact, community-engaged cancer
disparities research. As a logical next step in my career development, this K22 will give me the skills required to
design, implement, and evaluate multilevel interventions to achieve HPV health equity. Findings and preliminary
efficacy estimates will inform an R01 application of a multi-site trial to test a multiple component intervention
addressing the complex, context-specific determinants of HPV vaccine hesitancy to motivate vaccination and
change behaviors. Ultimately, this K22 proposal will facilitate my long-term goal to build an independent research
program investigating community-driven solutions to reduce HPV disparities and advance the elimination of
cervical cancer.

Public health relevance
PROJECT NARRATIVE HPV vaccination among adolescents is suboptimal, and parental delays and refusals are common. Addressing the unique vaccine hesitancy concerns and information needs of underserved families is critical to increase vaccination. This study will engage multiple stakeholders to develop and pilot a tailored intervention to address HPV vaccine hesitancy among Black families to increase vaccine confidence, vaccination, and ultimately help reduce HPV-related cancer disparities.